Using in-vivo Real-time Biosensor to Evaluate Prodrugs Designed to Prolong Therapeutic Effects for Smoking Cessation.

ABSTRACT
Developing drugs that target the central nervous system (CNS) is hampered by an inability to perform direct in
vivo preclinical measurements. Here, we propose to identify an optimal smoking cessation drug candidate by
monitoring how our newly synthesized prodrugs alter real-time brain dopamine responses to nicotine.
Varenicline (CHANTIX®) is the leading FDA-approved oral medication for smoking cessation. However, only
22% of patients maintain abstinence for 52 weeks following varenicline treatment1 and 67% of patients stop
treatment prematurely2, suggesting that therapies with better patient compliance are needed. To address this
need, we recently developed extended-release prodrugs that are designed to improve the pharmacokinetic
properties of varenicline. Varenicline reduces nicotine craving and use by dual action: first providing a transient
increase in dopamine levels and subsequently by blocking the dopamine response to nicotine3-5. These
changes aim to stabilize dopamine signaling in the brain to achieve two goals: (1) reduce the side effects of
transiently dopamine increases and (2) prolong the duration with which the drug reduces the reward value of
nicotine. In this Phase I grant, we will use an in vivo dopamine biosensor to evaluate real-time dopamine levels
in the striatum (a reward center in the brain) following administration of our novel prodrugs. We will establish
an in vivo relationship between brain efficacy (as defined by dopamine release) and drug levels in circulation.
These studies will allow us to screen for prodrugs that have optimal efficacy for altering both the level and
duration of dopamine response, which we use as a biomarker for predicting efficacy for smoking cessation.
The primary hypothesis of this Phase I grant is that a prodrug that stabilizes the initial dopamine release in the
striatum while also more efficiently blocking subsequent dopamine responses to nicotine will be more effective
than varenicline at decreasing IV self-administration of nicotine. We will test this hypothesis by: 1) establishing
pharmacokinetics for each prodrug relative to varenicline; 2) measuring striatal dopamine levels using real-time
in vivo biosensors to determine how different exposure curves affect dopamine response; and 3) assessing
behavioral changes in response to the prodrugs using a well-established nicotine addiction model. Our initial
pilot data demonstrate that, in comparison to varenicline, our prodrugs favorably alter the dopamine release
profile in the striatum. Thus, our prodrug approach changes the physiological function of the reward system
and may be a better drug for clinical use. Importantly, the core technology used in this grant to develop
improved smoking cessation drugs can be utilized more broadly as a general pharmacodynamic assay for
CNS drug development. Therefore, this research will provide a platform for drug discovery using in vivo real-
time methodologies. SpaceRx has extensive experience making varenicline analogs and prodrugs, and real-
time biosensing and measuring neural activity dynamics is a core technology of the Betley laboratory, making
our team ideally suited to test our hypothesis to successfully develop novel smoking cessation drugs.

Public health relevance
PROJECT NARRATIVE Varenicline (CHANTIX®) is the leading FDA-approved oral medication for smoking cessation. However, continuous abstinence 52 weeks following a 12-week treatment is only 22%1,2 and over 67% of patients stop treatment prematurely demonstrating that better therapies are needed. The use of in vivo biosensors to measure dopamine response in real-time is a novel approach that we will use to select prodrugs that stabilize basal dopamine levels and reduce both the dopamine response to nicotine and the self-administration of nicotine. These drugs, acting with longer duration and increased efficacy in comparison to varenicline, could lead to a single daily dose smoking cessation treatment with significantly better efficacy and less side-effects than the current standard of care.